THE MECHANISM OF OUTER HAIR CELL MOTILITY

DESCRIPTION: (Adapted from the Investigator's Abstract) The outer hair cell (OHC) of the mammalian cochlea, a sensory receptor cell, generates force when electrically stimulated. OHC force, driven in vivo by the acoustic receptor potential, is thought to contribute an extra step of mechanical excitation (the "cochlear amplifier") that improves tuning and is vulnerable to disease and insult. Recent experiments in this laboratory have shown that the axial stiffness of the OHC is essential to connect the OHC voltage-dependent motor to its load, the organ of Corti. But nothing is known about OHC stiffness at relevant acoustic frequencies nor are the cellular components underlying OHC stiffness understood. This proposal has three specific aims that will provide this information. In Aim1, OHC impedance (stiffness) will be measured directly at acoustic frequencies using a novel instrument, the laser stretcher. Whether membrane potential modulates impedance-a proposed mechanism of the cochlear amplifier-will be tested. The first direct measurement of isometric force will be made. In Aim 2, the role of OHC stiffness in the development of hearing will be determined, specifically whether the onset of OHC stiffness is a limiting event in development of the cochlear amplifer. In Aim 3, the role of the cortex, a subcellular structure in OHC stiffness will be determined using a developmental approach.